Core B: Proteomics and Metabolomics

Core B Summary
The Proteomics and Metabolomics Core (Core B) provides state-of-the-art instrumentation, methodology, and
expertise in analytical proteomics and metabolomics to investigators in this PPG. A unique feature of the
Proteomics and Metabolomics Core is the availability of cutting-edge quantitative proteomics analysis
technologies that allows high sensitivity measurements of proteome changes in models of gastric cancer. New
services in this renewal application include discovery and targeted metabolomics as well as tissue imaging
mass spectrometry (IMS). The Core provides 1) identification and quantitation of proteins in complex samples,
2) analyses of protein modifications, including phosphorylation, 3) quantitative analyses of metabolite
abundances, and 4) molecular imaging of gastric tissue using IMS.
Core staff provide consultation on experimental design as well as hands on sample preparation, mass
spectrometry analysis and primary data analysis. Multiple high performance mass spectrometers for LC-
MS/MS experiments are available for proposed analyses. In addition, advanced methods are available
including: multidimensional LC-MS/MS for protein identification from complex samples, TagRecon database
searching analysis for identification of unanticipated modifications or sequence variants from MS/MS data, and
high spatial and mass resolution imaging methods for tissue analysis. The Core also provides relative
quantitation using stable isotope differential labeling strategies, iTRAQ and SILAC, for samples derived from
animal models or from cell culture, respectively. Validation of protein expression or metabolite abundance
changes is accomplished using targeted multiple reaction monitoring LC-MS/MS methods.
Project 1 (Peek) will utilize metabolomics methods to measure metabolite changes in H. pylori strains isolated
from infected iron deplete or replete gerbils as a function of time. Project 2 (Wilson) will utilize phospho-SILAC
to measure changes in the phosphoproteome and metabolomics to measure metabolite changes in
macrophages upon H. pylori infection and with EGFR or DHPS inhibition. Project 3 (Cover) will employ
metabolomics methods to examine metabolite changes in plasma and gastric tissue. In addition, this project
will utilize IMS methods to measure changes in metabolites, proteins and lipids in gastric tissue in a spatially-
resolved manner as a function of dietary salt, infection and inflammation.
!

Public health relevance
Core B Narrative The use of state-of-the-art proteomics, metabolomics and imaging mass spectrometry technologies in the three Projects will identify protein, lipid, and metabolite changes in gastric cells, macrophages and bacterial cells that play important roles in gastric cancer. !